Resilience to prenatal stress: Implications for offspring health and neurodevelopment

PROJECT SUMMARY
Consistent with the Developmental Origins of Health and Disease theory, prenatal stress can have
enduring effects on offspring health and may be a major pathway through which stress-related health problems
are transmitted across generations. This transmission of risk disproportionately impacts marginalized groups,
such as people of color and families living in under-resourced communities who experience lifelong inequities in
social determinants of health (e.g., discrimination, access to healthcare, neighborhood violence). Strengths-
based models are lacking in prenatal research, and there is limited understanding of resilience-promoting factors
that may buffer the impact of chronic stress exposure on maternal stress responsive systems and placental
function. Research conducted via our current ECHO award has contributed to evidence supporting the
preconception period as an important window of vulnerability to the effects of stressors on maternal and child
health. In this renewal, we leverage ECHO data to examine the extent to which nutritional status and social
support/connectedness attenuate the negative effects of stressors on child neurodevelopment across racially
and socioeconomically diverse groups. Our ECHO Cohort will continue to enroll participants from the ongoing,
longitudinal Pittsburgh Girls Study (PGS), an urban-population sample of 2,450 women (now ages 26-29) who
have been followed since childhood. PGS participants (n=568, 69% Black, 27% White, 4% multi-racial) have
been enrolled into the ECHO Study as they become pregnant; a further 609 individuals will be recruited in the
renewal period, yielding a total Cohort of 1,177. Extensive preconception data are available from the PGS for all
existing and future ECHO participants. Guided by our Community Stakeholder Partner Board, we will implement
the ECHO Protocol with high fidelity, and propose innovative, specialized measures of prenatal stress exposure
(i.e., maternal hypothalamic-pituitary-adrenal axis functioning and placental CRH) and child executive function
and stress reactivity that can be readily deployed across ECHO Cohort sites. Thus, in response to RFA-OD-22-
018, we will advance the development, production, and dissemination of ECHO Cohort solution-oriented
collaborative science with the following Specific Aims: 1) Elucidate health and contextual factors that attenuate
the impact of prenatal stress exposure on child neurodevelopment; 2) Examine associations between stress
exposure, prenatal stress reactivity and offspring neurodevelopment; 3) Maximize participant retention, ensure
sample diversity and implement the ECHO protocol with high fidelity; and 4) Explore the timing and cumulative
effects of stress exposure on child health outcome. Our diverse, multidisciplinary team, representing wide
ranging identities, backgrounds and perspectives, has expertise in every aspect of the proposed study and is
highly qualified to lead collaborative cohort science in the renewal phase of the ECHO project. Achieving the
stated aims of the proposed study will advance knowledge on specific, measurable targets for tailored
approaches to the prevention of neurodevelopmental problems in children, including those at highest risk.

Public health relevance
PROJECT NARRATIVE Relevance to Public Health Prenatal stress is a known risk factor for negative child health outcomes, and disproportionately affects families facing racial and economic marginalization. We will examine the effects of preconception stress exposure on pregnancy health and neurodevelopmental outcomes in the child from birth to age 10, as well as the extent to which prenatal nutritional health and social support foster resilience in stressful environments. The findings from this study will advance knowledge on tailored approaches to optimize prenatal health and child development and reduce persistent health inequities.